ALLERGEN GENE VACCINATION IN MOUSE MODEL OF FOOD ALLERGY

DESCRIPTION: The applicant, Dr. Anthony Horner, is an assistant clinical professor of pediatrics at the University of California at San Diego. Dr. Horner trained in allergy and immunology at Boston Children's Hospital from 1991 - 1994, where he studied the CD40 ligand (CD40L) under Dr. Raif Geha. He came to UCSD in 1994 and until recently continued to work on CD40L. Drs. Eyal Raz and Dennis Carson are serving as mentors for the applicant. Dr. Kim Barrett will serve as a consultant/collaborator. The applicant's goals for this project are (1) to acquire further laboratory skills in the area of molecular biology and the use of animal models of allergic disease, (2) to further develop his intellectual skills as a physician scientist, and (3) to create a center of excellence for the diagnosis and management of food allergies at UCSD. The applicant proposes to explore the potential of plasmid DNA (pDNA) immunization to inhibit and reverse Th2-mediated allergic hypersensitivity to orally administered antigen. He will use an established mouse model of oral allergy and anaphylaxis to characterize protection against a Th2-mediated response by (1) intra-dermal allergen gene vaccination using pDNA encoding both allergen and immunostimulatory (IS) sequences and (2) intra-dermal co-injection of native protein plus single domain IS sequence-enriched pDNA. The applicant will then characterize the cellular components of the immune response to vaccination which are required for the development and maintenance of Th1-mediated immunity and the exclusion of Th2-mediated allergic hypersensitivity.